2015 Science of Adhesion Gordon Research Conference & Gordon Research Seminar

? DESCRIPTION (provided by applicant): The Gordon Research Conference (and, more recently, the affiliated Gordon Research Seminar) on the Science of Adhesion bring together every two years a community with expertize and interests in interfacial and surface phenomena, with an emphasis on the relationship between structure & chemistry, and interfacial mechanical properties. The 2015 GRC/GRS on the Science of Adhesion will focus on two (related) areas of strong current and future interest: adhesion and surface properties of soft/compliant materials, and application of adhesion science to biomaterials ranging in scale from individual molecules to tissues. The latter part of the focus of the 2015 GRC/GRS on Science of Adhesion relates closely to several of NIBIB program areas (http://www.nibib.nih.gov/research/scientific-program-areas), such as Biomaterials, Mathematical Modeling, Simulation, and Analysis, Micro-Biomechanics, and Integration of Implantable Medical Devices. Over the last decade, biological adhesion problems have become a regular and growing part of the Adhesion Science community. The GRC/GRS represents an opportunity to promote collaboration between the biology & bioengineering and the adhesion science communities that no other GRC provides.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project seeks partial support for the Gordon Research Conference and Seminar on the Science of Adhesion, specifically its focus on adhesion issues in biomolecules, cells and biomaterials. It is a goal of this GRC & GRS to build collaboration between the methods and techniques of established adhesion science, and scientific questions regarding the behavior of soft biomaterials since the latter often involve surfaces and interfaces and their physical/mechanical properties such as adhesion.